Data Coordinating Center for Spinal Manipulation and Patient Self-Management for Preventing Acute to Chronic Back Pain (PACBACK)

SUMMARY. The US is in the midst of an unprecedented pain management crisis. Low back pain (LBP) is the
most common chronic pain condition in adults and the leading cause of disability worldwide. Guidelines have
recommended non-pharmacologic treatments like spinal manipulation and behavioral approaches for LBP for
nearly a decade, however uptake in practice has been poor. Little is known about the role of these treatments
in secondary prevention of chronic LBP (cLBP), especially for patients with biopsychosocial risk factors. With
burgeoning costs of cLBP and mounting evidence of ineffectiveness and harms of commonly used drug
treatments, including opioids, there is a critical need for research on non-pharmacological treatments for cLBP
prevention that can be readily translated to practice.
The long-term objective is to reduce overall LBP burden by testing scalable first-line non-pharmacologic
strategies that address the biopsychosocial aspects of acute/sub-acute LBP and prevent transition to cLBP.
We propose a novel randomized hybrid trial addressing both effectiveness and implementation. A total of 1180
patients will be enrolled with nonspecific LBP of 2-12 weeks duration, at medium and high risk of developing
cLBP using the Subgroups for Targeted Treatment (STarT) Back Screening Tool (SBST). Aim 1 will assess
the effectiveness of Spinal Manipulation Therapy (SMT), Structured Self-Management (SSM), and SMT+SSM
relative to Usual Medical Care (UMC) in a randomized trial using a 2x2 factorial design. Primary outcomes are
prevention of cLBP at 12 months; recovery from acute/sub-acute LBP at 6 months; and cumulative reduction of
pain and disability over 1 year. Secondary outcomes include PROMIS-29, productivity loss, health care use,
and medication use (including opioids). Aim 2: will use mixed methods to gather data about important
influences on the interventions that could affect results interpretation and future implementation.
Aligned with the National Center for Complementary and Integrative Health's (NCCIH) Strategic Plan 2016, this
project has the potential to significantly transform LBP management by providing definitive and generalizable
evidence regarding front-line non-pharmacologic interventions addressing physical and psychosocial factors
for the prevention of cLBP. By empowering patients to engage in healthy pain management behaviors, we
anticipate LBP related disability, productivity loss, and reliance on continued health care and medication use
(including opioids) will be reduced. The comprehensive dissemination and implementation strategy, informed
by major stakeholders, will facilitate translation into clinical practice across health professions.

Public health relevance
The US is in the midst of an unprecedented pain management crisis, with chronic pain affecting over one third of adults. Low back pain is the most common chronic pain condition exacting a huge toll on society in terms of suffering, disability and costs, including those related to opioid misuse, addiction and overdose. Consequently, improving front-line LBP management with non- drug treatments that can prevent LBP from transitioning to chronic has become a critical public health priority.